Intervention to improve parent communication about sexuality with sexual minority male adolescents

Project Summary
Parental acceptance after youth come out as LGBTQ is a protective factor for the health of this youth group;
however, parents lack support in initiating and sustaining sexuality discussions inclusive of their teens’
attractions, behaviors and identities. Thus, in the absence of skills and supports, adolescents’ and parents’
mental health, health behaviors and overall family functioning tend to be negatively impacted after cisgender
sons come out as gay, bisexual and queer (GBQ). The overall objective of this application is to test the
efficacy of Parents ASSIST (Advancing Supportive and Sexuality Inclusive Sex Talks), a sexuality
communication intervention for parents, after youth disclose GBQ identities. We will conduct a randomized
controlled trial with parent and GBQ youth dyads (N=476) to establish the efficacy of Parents ASSIST as a
hybrid 5-session online intervention that educates parents about germane LGBTQ-topics and provide
communication skills for inclusive family discussions. Our Specific Aims are to (1) determine whether Parents
ASSIST enhances parent-adolescent sexuality communication quality (e.g. parent- and child-reported comfort)
and quantity (e.g. frequency and range of topics discussed) compared to the control group, (2) establish
whether Parents ASSIST results in decreases in mental health symptomology (e.g. depressive and anxiety
symptoms) among parents and GBQ youth, increases dyadic health behavior (e.g. accessing preventive health
services, health screening behaviors), and improves family functioning (e.g. affective response,
communication, general functioning) over 12 months of follow-up, and (3) examine how theory-based variables
(e.g. attitudes and norms, self-efficacy and intentions to discuss sexuality with GBQ child) mediate the
intervention effects on adolescent and parent mental health, parent-adolescent health behavior and family
functioning over time. This proposal is innovative because it is one of few studies that investigate the role of
parent-adolescent sexuality communication with GBQ youth, it examines both individual and dyadic health
outcomes, and the study will include analyses on the differential effects that racial/ethnic factors may play on
GBQ youth and parents’ health outcomes to break new ground in addressing longstanding health disparities.
Ultimately, fortifying the capacity of parents to initiate and broach sexuality-sensitive communication with GBQ
sons offers new opportunities for families to be protective of all sexual and gender minority youth.

Public health relevance
Project Narrative Parents require skills to initiate and sustain protective family communication about sexuality and health with gay, bisexual, or queer (GBQ) male adolescents. The proposed study is relevant to public health as it is centered on helping parents answer and meet the sexuality-specific questions and needs of GBQ youth after they disclose sexual orientation. This study seeks to test the efficacy of Parents ASSIST as a parent-child sexuality communication intervention that educates and trains parents to be purveyors of inclusive health information as GBQ sons come of age at home.